The Effects of Medicaid Reimbursement of Immediate Postpartum Long-Acting Reversible Contraception on Reproductive Health Outcomes

More than half of repeat pregnancies with short interpregnancy intervals (≤18 months between live birth and
conception of a subsequent pregnancy) are unintended.1 Unintended and short interval pregnancy has
significant adverse health and socioeconomic outcomes for women and their families. The immediate health
impacts include increased risk of preterm birth, low birth weight, preeclampsia, maternal depression and
intimate partner violence, and lower rates of breastfeeding.2-5,20 In the longer-term, unintended childbearing is
associated with higher rates of poverty and less family stability.8 Young, poor, black and Hispanic women, and
women of lower income or education are more likely to experience unintended short interval pregnancy.6,7 Due
to these consequences, a 2030 Healthy People objective is to reduce short interval pregnancies by 20%.9
Receipt of highly effective birth control like long-acting reversible contraception (LARC) in the immediate
postpartum period (IPP; time between delivery and hospital discharge) can reduce unintended and short
interval pregnancy. Yet, 40-75% of women who plan to use a LARC method postpartum do not receive it.10 A
primary barrier to widespread adoption of IPP LARC has been the inability to obtain reimbursement for LARC
devices and insertion provided immediately postpartum. To address this barrier, some state Medicaid
programs have started to reimburse for IPP LARC insertion, for the device, or both outside of the
reimbursement of labor and delivery costs. Absent this policy, states pay for labor and delivery services using a
“bundled” payment that does not allow for reimbursement of individual procedures, drugs, or devices. Existing
evidence for Medicaid IPP LARC reimbursement is limited to analyses within single hospitals or single states
looking at short-term effects of policy adoption (e.g., hospital implementation and LARC uptake) or rely on
methods that assume that all factors affecting pregnancy outcomes can be accounted for with covariates. This
study seeks to fill gaps in the evidence by examining long-term, population-level effects utilizing a quasi-
experimental research design. First, I will estimate the effect of Medicaid IPP LARC reimbursement policy on
the probability of using a LARC method postpartum and probability of an unintended pregnancy. Next, I will
estimate the effect of the reimbursement policy on the risk of short interval pregnancy. Lastly, I will estimate the
extent to which hospital type impacts the risk of short interval pregnancy. Three types of hospitals, teaching
hospitals, hospitals with a high proportion of Medicaid patients, and 340B entities, may be more responsive to
the policy change because these hospitals serve populations of women at increased risk for short interval
pregnancy and have supportive structures to successfully implement a IPP LARC program.12,13 This proposal
is aligned with multiple AHRQ research priorities, including racial/ethnic minorities, low-income, women, and
access to care.

Public health relevance
PROJECT NARRATIVE Beginning in 2012, some state Medicaid programs began providing separate reimbursement for immediate postpartum (IPP) long-acting reversible contraception (LARC) in the hospital setting to increase the availability of highly effective birth control and improve reproductive health outcomes. The proposed study aims to estimate the impact of Medicaid IPP LARC reimbursement on postpartum LARC use and the occurrence of unintended and short interval pregnancy among Medicaid-insured women. In addition, it will examine the role of hospital type on successful policy implementation.